Development of novel molecular or phenotypic databases

Current initiatives in this area include RNA sequencing and DNA methylation initiatives. In addition, we hope to add omic protein expression level data from mass spectrophotometry, and possibly parameters of cell migration. Additional forms of data will be explored as opportunity permits. These datasets will then be incorporated into CellMiner in such a fashion as to make then accessible and usable to the scientific public. This will include each being developed into its own Cell line signature to facilitate its comparison to other data types, and its inclusion into our Pattern comparison tool to allow its integration with and comparison to our other 68,970 phenotypic and molecular patterns.